Circadian Regulation of Epithelial Immune Reponses in Asthma

Project Summary/Abstract
Circadian rhythms of cellular function and physiology are important signals for health, particularly in the lungs
and in respiratory diseases. In diseases such as asthma, nocturnal symptoms are a key feature and
exacerbations beginning at night from viral infections frequently result in emergency room visits or
hospitalizations, but the biology underlying why symptoms and exacerbations occur more often at night is not
well understood. Cellular circadian rhythms occur due to intrinsic oscillations of gene expression in a molecular
clock that regulates numerous immune genes and pathways implicated in diseases such as asthma. Prior
research in mice has indicated that the molecular clock function in airway epithelial cells is important in
regulating innate epithelial immune responses to viral infections. However, investigation of circadian regulation
in human cells and in clinical diseases such as asthma has been limited. The research proposed in this project
will address a current gap in knowledge of circadian regulation in human airway and lung diseases. The project
will use an existing biorepository of primary human airway epithelial cells differentiated to an organotypic state
at an air-liquid interface from healthy donors and donors with pediatric asthma. Aim 1: Measure viral replication
and airway epithelial innate immune responses to human rhinovirus infection in AEC cultures in relation to
cellular circadian time. Aim 2: Compare the pattern of circadian cyclic gene expression of innate immune
pathways in the airway epithelium of children with asthma and healthy children. Aim 3: Characterize the impact
of circadian disruption on epithelial immune responses to infection. The proposed studies will identify epithelial
immune pathways under circadian regulation in human airway epithelial cells that can lead to novel therapeutic
strategies in the treatment of viral infection and asthma through a circadian biology informed approach. Dr.
Powell’s career development plan builds on his background in molecular and cellular biology and clinical
expertise in pulmonary and sleep disorders to add training in epithelial innate immunity and viral studies using
mechanistic translational approaches, developing expertise in circadian bioinformatics, and methods for
molecular manipulation of the core circadian clock in primary human airway epithelia. The K08 award is well-
structured to make maximal use of the extensive resources at Seattle Children’s Research Institute and the
University of Washington while leveraging the expertise of a mentorship team comprising experts in airway
biology, circadian biology, circadian regulation in pulmonary disease, and bioinformatics. The award will lead
Dr. Powell to a productive, independent career as a physician-scientist investigating circadian biology in human
lung diseases to guide novel therapeutic development.

Public health relevance
Project Narrative Circadian rhythms underlie numerous cellular functions in the lung, including how airway epithelia respond to viral infections in health and in diseases such as asthma. The aim of the proposed work is to provide mechanistic investigations of circadian regulation of epithelial immunity in human airway cells and how altered responses contribute to asthma and asthma exacerbations. The long term goal will serve an important need in providing biological knowledge of how to provide the optimal drug, in the optimal patient, at the optimal time of day.